Brain and Behavioral Responses to Backward Walking Training Post-Stroke

Background/Purpose: Physical rehabilitation of walking post-stroke is designed to improve individuals' mobility
in the presence of motor, sensory and balance impairments. Effective strategies to improve balance and
decrease fall risk continue to be a need in stroke rehabilitation. To address this, our laboratory has studied a
novel Backward Walking Training program (BWTraining) to improve both forward and backward walking speed
as well as balance in individuals with both acute and chronic stroke. Our prior published work has
demonstrated that this intervention is safe, feasible and effective, however, critical questions remain
unanswered regarding how best to deliver this intervention for optimal impact. The primary aim of this proposal
is to establish dosage effects of BWTraining for maximizing gains in forward walking speed, backward walking
speed, and dynamic balance. Additionally, we will determine baseline brain MRI predictors of response to
BWTraining intervention and explore changes in brain activity as a result of this behavioral intervention. We are
interested in understanding how individual differences in structural and functional brain measurements might
distinguish between responses to BWTraining. This information will promote prudent decision-making as to
which patients are good candidates for this novel intervention. We will conduct a randomized controlled trial
with three specific aims to test the 1) Dose effect of number of BWTraining sessions on walking speed and
balance, 2) the ability of resting state Functional Connectivity (rs-FC) between specified brain regions and
Blood Oxygen Level-Dependent (BOLD) activation of brain Regions Of Interest (ROIs) during task-based fMRI
to predict BWTraining outcomes and 3) changes in both rs-FC and BOLD activation during contralateral ankle
motion following BWTraining intervention compared to baseline.
Study Design: This is a randomized single-blind controlled trial.
Subjects: Forty-eight individuals, 2-4 months post-stroke, will meet the following study criteria: 1) ambulatory
with gait speed < 0.8 m/s; 2) community-dwelling; 3) Berg Balance Scale < 42; 4) absence of other
neurological conditions; 5) stable cardiac status; 6) absence of lower extremity orthopedic impairments or pain
that limits gait ability; 7) absence of metal and Magnetic Resonance sensitive implanted medical devices.
Methods: Following baseline Assessment A, participants will be randomized to an 18 or 27 session
BWTraining group. BWTraining intervention (3X/week for 6 or 9 weeks) consists of 20–30 minutes of step
training using a Body Weight Support and Treadmill system followed by 20 minutes of overground gait training.
Assessment B will occur after the final training session for each group. Assessment C will occur 6-weeks post-
intervention and Assessment D at six months post-intervention for both groups. Magnetic Resonance Imaging
of the brain consisting of rs-FC and BOLD blood flow in ROI's during an ankle motor task will be assessed at
Assessments A and B to address Specific Aim 2 and Specific Aim 3 respectively.
Outcome Measures: Primary outcome measure is forward gait speed. Secondary measures include backward
walking gait speed, dynamic balance measured by the Functional Gait Assessment and Center of Mass
Asymmetry, fall self-efficacy and spatial-temporal gait measures.
Data Analysis Plan: A sample size of 48 (24/group) provides 80% statistical power to detect a 0.11 m/s
difference in post-intervention gait speed between the 18- and 27-session groups at a 5% significance level
using a two-sample t-test. To assess training dose effect, a two-sample t-test will be performed on the primary
outcome, forward walking speed. The ability of rs-FC and BOLD activation of ROI's conducted pre-intervention
to predict intervention response will be assessed based on the correlation with gait speed change. Mean
connectivity strength for each network and mean signal intensity strength for each ROI will be compared pre-
to post-intervention.

Public health relevance
Approximately 15,000 Veterans are hospitalized for stroke each year with new cases costing an estimated $111 million for acute inpatient, $75 million for post-acute inpatient, and $88 million for follow-up care over 6 months post-stroke. We have previously established the effectiveness of a backward walking training program to improve gait and balance in post-stroke Veterans. To best serve our Veterans in this era of personalized medicine, there is a current need to determine the appropriate training dose as well as which post-stroke Veterans would most benefit. This study addresses both needs as it will 1) test responses to two different doses (18 vs. 27 sessions) of backward walking training and 2) assess brain activity, measured by magnetic resonance imaging, before and after training intervention to determine its ability to predict rehabilitation response as well as brain mechanisms of behavioral change.